Comparative Modeling of Precision Breast Cancer Control Across the Translational Continuum

ABSTRACT
The CISNET Breast Working Group (BWG) proposes innovative modeling research focused on new precision
oncology paradigms that are expected to re-define breast cancer control best practices. We selected
significant topics where modeling is suited to fill evidence gaps and facilitate clinical and policy translation.
Unique components of our approach include modeling of absolute risk of disease accounting for multiple risk
factors, addressing important comorbidities—specifically type 2 diabetes—that affect both disease risk and
survival, exploring emerging biomarker-based approaches for screening, providing guidance regarding
precision systemic treatments and their impact on quality of life in survivors, and investigating race disparities.
The specific aims are to: 1) Evaluate the impact of novel precision screening approaches; 2) Evaluate the
impact of precision treatment paradigms in the adjuvant, neo-adjuvant, and metastatic setting; 3) Synthesize
Aims 1 and 2 to quantify the contributions of precision screening and precision treatment to US breast cancer
mortality reductions; and 4) Provide evidence to guide interventions to reduce race disparities by quantifying
multiple risk, screening, treatment, and survival factors that impact disparities. This scope of work would not be
feasible without the availability of six distinctive BWG models: Dana Farber (D), Erasmus (E), Georgetown-
Einstein (GE), MD Anderson (M), Stanford (S) and Wisconsin-Harvard (W). The aims encompass multiple RFA
priority areas, and we have set aside Rapid Response funds to address remaining priority areas, support
cross-cancer CISNET collaborations, and foster junior career enhancement. Each aim includes three or more
model groups selected for their unique structure and includes outside collaborators and junior investigators.
The models will share common inputs and provide a standard set of outcomes for benefits (e.g., distant
recurrences and deaths avoided, mortality reductions, distant disease-free survival, and life years and quality-
adjusted life years), harms (e.g., false positives and benign biopsies, interval cancers, advanced stage
diagnoses, overdiagnosis and treatment impact on quality of life), and costs. Continuously funded for the past
19 years, the modeling teams have published 204 research papers informing public health policy decisions and
trained 13 junior investigators. For this proposal, the BWG will partner with the American Cancer Society, the
American College of Radiology, the American Society of Clinical Oncology, the Breast Cancer Surveillance
Consortium, and others. An experienced Coordinating Center provides the infrastructure to support the project
goals including resource sharing and model accessibility. The exceptional environment provides
unprecedented synergy and leveraging of resources to address new research questions and support career
development that would not otherwise be possible. Overall, this research will advance modeling research and
guide breast cancer control policy.

Public health relevance
NARRATIVE The rapid pace of discovery about breast cancer biology has given rise to survival gains and new precision screening and treatment approaches. The overarching goal of our application is to use collaborative computer modeling to inform translation of precision oncology evidence to clinical guidelines and policy by evaluating strategies to further decrease mortality, understand survivor quality of life, and reduce disparities. We will use six breast cancer simulation models as a virtual laboratory to inform policy and clinical decisions by evaluating the impacts on mortality, quality of life, harms, and costs of disseminating these evolving precision cancer control paradigms.